OCT imaging of the human inner ear

Project Summary/Abstract
A sudden drop in hearing in a previously healthy adult patient is a common patient presentation. Medical terms
that are used to describe the various forms of this disorder include sudden sensorineural hearing loss, cochlear
hydrops, Meniere’s disease, and autoimmune inner ear disease. However, the underlying pathophysiology is
poorly understood. To date, post-mortem temporal bone histopathology and animal models have provided the
best data about these conditions, and it appears that a relatively common finding is increased endolymph
volume, termed endolymphatic hydrops. The link between endolymphatic hydrops and human hearing loss has
not been established. Here we propose to use optical coherence tomography (OCT), an imaging technique
based on the use of low-power light, to visualize the fluid compartments of the human inner ear. We have built
a device that permits us to see inside the lateral semicircular canal and measure the relative amounts of
endolymph and perilymph. We will characterize the normal endolymph-to-perilymph ratio in control subjects
undergoing mastoid surgery for middle ear disease who have normal cochlear function. In addition, we will
compare the endolymph-to-perilymph ratio in subjects with Meniere’s disease and vestibular schwannoma who
are undergoing mastoid surgery to treat their disease. If our hypotheses are correct, the endolymph-to-
perilymph ratio will be tightly regulated in normal controls but elevated in subjects with inner ear disease. Thus,
this study is designed to validate the use of OCT for human inner ear imaging and to support the use of the
endolymph-to-perilymph ratio as an outcome measure for clinical trials of new treatments for Meniere’s
disease. This exciting technology may also offer new approaches to assessing outcomes of innovative
treatments of hearing loss or vestibular dysfunction, such as hair cell regeneration or gene therapy.

Public health relevance
Project Narrative Diseases of the inner ear lead cause patients to experience hearing loss and dizziness, but unfortunately, we have no effective way to guide the treatment of these disorders because current clinical techniques cannot image the delicate tissues within the inner ear that underlie these problems. Here we will validate the use of optical coherence tomography, a safe high-resolution imaging technique that uses low-power light, to see inside the human inner ear in normal controls, in subjects with Meniere’s disease, and subjects with vestibular schwannoma. This exciting technology may provide a better approach to diagnosing the cause of hearing loss and dizziness in individual patients, as well as provide a better way to monitor the effectiveness of treatment.